Interaction between c-di-GMP and cAMP signaling in Pseudomonas aeruginosa biofilms

PROJECT SUMMARY/ABSTRACT
Bacterial biofilms are microbial communities with aggregates of bacterial cells enclosed in an extracellular matrix.
Biofilms present a significant healthcare challenge because of their prevalence in infectious diseases and
resistance against treatment. Second messengers, which are critical intracellular signaling molecules that are
produced in response to environmental stimuli, play a key role in biofilms. The regulation of these signaling
pathways is a fundamental question in microbiology and biofilm research. In particular, the second messenger
molecules cyclic diguanylate monophosphate (c-di-GMP) and cyclic adenosine monophosphate (cAMP) play
critical roles in biofilm formation in many bacterial species. The opportunistic pathogen Pseudomonas
aeruginosa is a model species for studying biofilms. My postdoctoral work has developed a tricolor reporter
system to simultaneously study c-di-GMP and cAMP signaling at the single cell level in P. aeruginosa. Using this
system, I found that c-di-GMP and cAMP signaling are activated under distinct surface conditions during the
initial stages of biofilm formation, when bacteria attach and respond to a surface. This proposal aims to elucidate
the molecular coordination between c-di-GMP and cAMP signaling and their roles in later stages of biofilm
formation. Aim 1 will characterize how cAMP influences the enzymatic activity of c-di-GMP cyclase and
phosphodiesterase, identify the enzyme targeted by cAMP, and investigate the role of an unknown protein
PA3413. Aim 2 will examine how c-di-GMP impacts the three key proteins controlling cAMP signaling and employ
an unbiased screen to identify additional genetic factors involved. Aim 3 will elucidate the coordination of c-di-
GMP and cAMP signaling during biofilm maturation and dispersion, particularly under host-related environmental
conditions. These aims will reveal the regulatory mechanisms between these two critical second messengers,
deepen our understanding of phenotypic heterogeneity within biofilm communities, and are expected to facilitate
future research into the broader regulatory networks of second messengers. This proposal also includes a career
development plan for me to successfully transition to an independent faculty position. I will leverage the guidance
of highly experienced mentor and co-mentors during the K99 mentored phase, gaining training in 1) second
messenger signaling, 2) biofilm cultivation and dispersion, and 3) live cell confocal microscopy. I will also
enhance my skills in mentoring, lab management, and scientific communication. In transition to the independent
R00 phase, I will apply these skills and use the data generated from the proposed studies to position myself for
a successful R01 grant prior to the end of this award.

Public health relevance
PROJECT NARRATIVE Signaling through the bacterial second messengers c-di-GMP and cAMP is exquisitely regulated and controls critical processes involved in biofilm formation, which is a significant factor in various infections. The proposed studies will elucidate the mechanisms by which c-di-GMP and cAMP negatively regulate each other and contribute to biofilm development using Pseudomonas aeruginosa as a model. The proposed experiments aim to improve our understanding of second messenger signaling, provide new insights into bacterial biofilm development, and ultimately lead to more effective therapeutics for treating infections.